TITLE: ANALYTICAL CHEMISTRY AND STABILITY TESTING OF TREATMENT DRUGS FOR SUBSTANCE USE DISORDERS. POP AUGUST 4, 2019 - AUGUST 3, 2020.

Period of Performance: 08/04/2019 to 08/03/2024

The Contractor shall provide services for analytical chemistry and quality controls of drug substances and/or finished
dosage forms in support of the National Institute on Drug Abuse's (NIDA) medication development programs.